Niclosamide Formulations for the Treatment of Influenza Infections

Project Summary
The principal goal of this project is to demonstrate that the FDA-approved anthelminthic drug,
niclosamide, can be reformulated in a synthetic lung surfactant which can be aerosolized for the treatment of
infections caused by respiratory viruses. The studies proposed in this SBIR Phase I application will be focused
on testing this concept by suspending niclosamide loaded liposomes in our proprietary lung surfactant
technology (Niclosurf) and testing candidate Niclosurf formulations in a mouse influenza challenge model. The
effectiveness of Niclosurf as a treatment for respiratory viral infections caused by influenza will be evaluated.

Public health relevance
Public Health Relevance Successful execution of the studies proposed in this application will establish the proof of concept for the use of niclosamide formulated in a synthetic lung surfactant as a treatment for respiratory viral infections such as influenza. Such an advancement is expected to be of significant impact for improving the treatment of respiratory viral infections, including SARS-CoV-2. Since niclosamide is already an FDA-approved drug, the path to clinical application of this niclosamide formulation for viral respiratory infections, if this study is successful, is expected to be relatively fast.